Accounting for measured and unmeasured heterogeneity in host populations

Project III: Accounting for Measured and Unmeasured Heterogeneity in Host Populations proposes a variety of studies to assess the contribution of host heterogeneity to model parameter estimation for infections with different transmission routes and creates models incorporating two key sources of such heterogeneity: virus interference and dose-response relationships.